WU-DDRCC Midwest DDRCC Alliance (MWA) Conference

Project Summary
The goal of this supplement is to obtain additional funds for the Midwest Digestive Disease Research Core
Centers (DDRCC) Alliance Conference, which is scheduled for April 8-9, 2022. The Midwest DDRCC
Alliance (MWA) is comprised of 6 NIDDK- funded DDRCCs located in the Midwest: Case Western Reserve
University, Cincinnati Children's Hospital, Mayo Clinic, University of Chicago, University of Michigan, and
Washington University in St Louis. The MWA Conference was initiated in 2013 to promote the career
development of postdoctoral and junior faculty members and to provide a forum for cross-fertilization of
knowledge and research progress among the participating institutions. The requested funds will allow the
conference to continue and also to expand opportunities for junior investigators' career development,
mentoring, and networking and to familiarize them with core services and scientific and technology expertise
available at the MWA partner sites. Finally, a major component of this supplement is to promote careers
of women and URM trainees as they seek to become investigators in digestive and liver disease. We will
feature successful women and URM investigators as role models and mentors and to expand our
community of researchers interested in digestive and liver disease.

Public health relevance
Project Narrative Digestive and liver diseases have a significant effect on public health and health care utilization costs. This supplement application requests support for a conference that nurtures junior investigators, particularly women and URM trainees, interested in digestive and liver disease research. Our goals are to provide additional mentoring support during a critical time in their career, and to familiarize them with the scientific and technological expertise available at Midwest Digestive Disease Research Core Centers.